Enhancing NCI-funded research at the University of Arizona Cancer Center

Abstract:
The University of Arizona Cancer Center (UACC) is the only NCI-designated comprehensive cancer center
headquartered in the state of Arizona. The catchment population covers the five southern counties of Arizona
and is close to 40% Hispanic while also including representation from many of the 22 federally recognized
Native American tribes in the state. This R50 proposal focuses on growing the clinical research enterprise at
UACC, specifically in NCI-funded research and through development of a clinical trials navigation program.
The plan for growth over the next five year includes growing the breadth of the clinical trial portfolio to be
accessible to the diverse populations seen at UACC while also increasing accruals to interventional treatment
trials, especially in NCI-sponsored trials and investigator-initiated trials (IITs). The clinical trial navigators will
work to increase clinical trial literacy and decrease barriers to participation. Part of this R50 effort is also
focused on growing the Arizona Clinical Trials Network (ACTN), which will bring novel therapeutic trials to the
underserved and underrepresented populations across the state, not just within our catchment. The ACTN will
increase diversity and representation in NCI-funded clinical trials in particular since this will be the initial set of
studies that we plan to open at pilot sites. UACC is uniquely positioned to increase its impactful reach by
leveraging the ACTN and providing comprehensive cancer care to rural and underserved areas in Arizona.
This proposal will provide time and effort to support my roles as UACC Site Principal Investigator (PI) for the
Southwest Oncology Group (SWOG) and as Associate Director of Clinical Investigations at UACC so that we
can increase the impact of our clinical research program and support the NCI’s interest in enhancing diversity
and inclusion in their research efforts.

Public health relevance
Project Narrative: The University of Arizona Cancer Center (UACC) serves a unique and diverse population and as such is poised to have true impact in cancer clinical research. Growing the UACC clinical research program as a whole and NCI-funded trials in particular is needed to advance drug development in oncology. This project will aim to increase accruals to cancer clinical trials with an emphasis on diversity and inclusion as we provide access to the Hispanic and Native American populations that UACC serves.